Advancing Targeted Therapies for Cushing's Disease Using Pituitary Neuroendocrine Tumor Organoids

PROJECT SUMMARY/ABSTRACT
Cushing’s disease (CD) is a serious endocrine disorder characterized by an adrenocorticotropic hormone
(ACTH)-secreting PitNET that subsequently stimulates the adrenal glands to overproduce cortisol. Chronic
exposure to excess cortisol has wide ranging and detrimental effects on health, including increased stroke rates,
diabetes, obesity, depression, anxiety and death. Although CD is linked to a threefold increase in the risk of
death, the advancement of current standard of care medical therapy is lacking. Current treatments exhibit low
efficacy and tolerability for patients. The first-line treatment for CD is pituitary surgery. In the hands of an
experienced surgeon, tumor recurrence occurs in as many as 56% of patients during the 10-year follow-up
period. Despite multiple treatments, biochemical control is not achieved in approximately 50% of patients,
suggesting that in routine clinical practice, initial and long-term disease remission is not achieved in a substantial
number of CD patients. Hence, medical therapy is often considered in the following situations: when surgery is
contraindicated or fails to achieve remission, or when recurrence occurs after apparent surgical remission. While
stereotactic radiosurgery treats incompletely resected or recurrent PitNETs, the main drawbacks include the
longer time to remission and the risk of hypopituitarism. Our research team has published data demonstrating
that organoids derived from corticotroph type PitNETs consist of differentiated cell lineages, stem/progenitor
cells, and immune and stromal cells that replicate much of the patient’s own tumor pathology, function, and
genetic alterations. Our team’s expertise in organoid technology has enabled the first successful development
and implementation of this advanced 3D culture in the much-needed PitNET research arena. Using human
PitNET organoids we have revealed stem and progenitor cell populations that express an antioxidant mechanism
that may be targeted to prevent tumor recurrence and medical- and radiation-therapy resistance
develop Specific Aims: 1) Take a noncommittal research approach to define the molecular
. This led us to
signatures of
corticotroph tumor subtypes in CD, and 2) Leverage the complementary value of the human hypothalamic-
pituitary-adrenal (HPA) Axis-On-A-Chip and the canine naturally occurring CD model to accelerate targeted
therapies for patients with CD. The objectives will be successfully achieved by collaborative efforts between the
University of Arizona (UA), Barrow Neurological Institute (BNI), University of Georgia Athens (UGA) that will
leverage the expertise of professionals trained in complimentary fields including surgical treatments, pathology
and cell biology of pituitary disease, organoid technology, canine preclinical in vitro and in vivo models and high
throughput data analysis including dug screening, molecular profiling, and transcriptomics. At the completion of
the funding period, we will be positioned to implement patient-relevant organoids to accelerate the development
of therapies that will effectively target ACTH-secreting pituitary adenomas in patients with CD.

Public health relevance
PROJECT NARRATIVE Expeditious diagnosis and effective treatment are essential for the positive long-term outcomes for patients with Cushing’s Disease (CD). Effective treatment of recurrence of disease remains a challenging task for endocrinologists and neurosurgeons. The proposed research will allow us to identify novel therapeutic approaches to effectively treat ACTH-secreting pituitary adenomas in patients with CD by targeting the tumor directly.